GENETIC STUDIES OF CRANIOFACIAL DISORDERS

The overall goal of this proposal is to determine genetic factors involved in human craniofacial development. The specific aim of this project is to evaluate the clinical phenotype of patients with craniofacial disorders.